Digital Phenotyping of Anxiety and Anxiety-Related Alcohol Comorbidity and Treatment

Project Summary
Anxiety and anxiety-related disorders (AARD) are notable risk factors for alcohol use problems (AUP) and
their co-occurrence (AARD-AUP) results in tremendous health costs and societal burden. The self-medication
model states that those with AARD use alcohol to numb or cope with arousing and distressing negative
emotional states; however, longitudinal evidence for self-medication is mixed and psychological treatments
integrate cognitive-behavioral therapy (CBT) skills for substance use disorders with CBT interventions for
AARD have demonstrated modest success. The heterogeneity in these findings is likely influenced by dynamic
and person-specific factors. We hypothesize that results from person-specific analyses can improve our
understanding of this heterogeneity and can be harnessed to personalize interventions for AUP. Personalized
interventions have the potential to increase symptom reduction and rate of change, as well as therapy retention
and alliance. Modeling person-specific patterns of psychopathology has been challenging due to historical
limitations with data collection and statistical analyses. However, increasing access to digital phenotyping –
an innovative method for collecting single-subject intensive ecological momentary assessment (EMA)
integrated with passive sensing smartphone data streams (e.g., GPS data, accelerometer, Bluetooth/call/SMS
data) – offers a compelling solution for the development and evaluation of truly personalized psychological
interventions. Such data can be used to generate statistical models of a single individual’s pattern of behavior
over time. Previous data-driven (i.e., feedback-based) interventions have demonstrated success; however, it is
unclear whether using person-specific models to adapt an active intervention reduces symptoms or improves
therapeutic efficiency (i.e., rate of change), therapeutic retention, or therapeutic alliance.
This K99R00 award will provide training in passive sensing data collection methods and conduct of clinical
trials, as well as continued training in alcohol research. In the K99 phase, I will build on previous expertise
constructing person-specific models and identifying person-specific factors testing self-medication models of
AARD-AUP, developing a method for personalizing a CBT skills-based intervention. In the R00 phase, the
feasibility of this intervention will be tested in a pilot three-group parallel randomized clinical trial (RCT), which
will test the feasibility of a personalized CBT skills-based interventions compared to two control conditions
testing the relative efficacy of personalization and personalization method, respectively. In the personalized
condition, the therapist will review identified influential factors from the person-specific model, treat these
factors using CBT skills, and track them using the mindLAMP digital phenotyping platforms – testing a data-
driven method for personalizing and adapting the content of each session. Findings will inform future
R01 applications testing personalized interventions for problematic alcohol use.

Public health relevance
Project Narrative Anxiety and anxiety-related disorders frequently co-occur with alcohol use problems resulting in an enormous humanitarian and economic cost to society. The proposed research will use digital technology to examine person-specific risk factors predicting problematic alcohol use in individuals vulnerable to anxiety and anxiety-related disorders and will use this information to design a personalized intervention for individuals seeking psychological treatment. Results from this research will integrate output from novel and innovative digital technology methods into psychotherapy, advancing research on personalized treatment and prevention efforts.